Defining mechanisms of action of Menin inhibition in AML

Abstract Project 3
Acute myeloid leukemia (AML), and specifically KMT2A-rearranged (KMT2A-r) and NPM1 mutant AML, remain
devasting disease with an overall poor prognosis for high risk pediatric and adult patients. AML is characterized
by aberrant transcriptional programs caused by dysregulated chromatin associated complexes. In particular, the
histone methyltransferase KMT2A and members of its large chromatin associated complex, including Menin and
DOT1L, are responsible for the stable aberrant expression of developmental genes, such as homeotic (HOX)
genes and MEIS1, which are key to the oncogenic program. Pharmacologic inhibition of the Menin-KMT2A
interaction by Menin inhibitors is currently in being assessed clinical trials has shown remarkable efficacy in
KMT2A-r and NPM1 mutant AML, providing potential new treatment options. While these promising clinical
results further support the importance of these key chromatin associated complexes, the lack of mechanistic
understanding currently limits further advances in the development of new treatments for this disease. Based on
recent data from our labs, we hypothesize that KMT2A and Menin containing complexes establish distinct
chromatin conformations that establish the oncogenic transcriptional program and that these distinct complexes
exist at specific loci. We further hypothesize that beyond blocking the Menin-KMT2A interaction, combination
with inhibitors of other complex members (DOT1L or KAT6A) or by degrading Menin through the use of
proteolysis targeting chimeras (PROTACs) would lead to improved efficacy. Specifically, in Aim 1, we will use
genetically engineered cell line models and advanced sequencing-based methods to interrogate the chromatin
structure induced and maintained by KMT2A and Menin dependent complexes. In preliminary data, we have
identified unique genomic conformations that support long range interactions between distinct Menin complexes
to support transcription at specific genes important for AML. We will study the precise composition of these
protein complexes using mass spectrometry-based proteomics approaches. In Aim 2, we will test the hypothesis
that the ubiquitin ligase UBR5 is critically involved in the stability of Menin- and KMT2A-containing chromatin
complexes. Based on our observation that UBR5 contributes to the destabilization of Menin and KMT2A post
Menin inhibitor treatment, we will interrogate how UBR5 mediated stability impacts chromatin occupancy,
chromatin conformation and transcriptional output mediated by RNAPII. In Aim 3, we will test the hypothesis that
combinations of drugs targeting multiple components of these epigenetic enzymes or the use of newly available
Menin directed PROTACs will enhance the efficacy of targeting these AML defining chromatin complexes and
thereby oncogenic transcription.

Public health relevance
ABSTRACT PROJECT 3 Despite significant progress in treating acute leukemia, acute myeloid leukemia (AML) continues to be a challenging diagnosis with a poor prognosis for both adults and children, highlighting a crucial area of unmet medical need. AML is characterized by the hijacking of normal transcriptional networks by large epigenetic complexes that suppress normal myeloid differentiation and drive malignant transformation. Thus, we propose an innovative strategy to target aberrant epigenetic control of gene regulation by (a) characterizing the unique protein complexes and chromatin structures controlling leukemic gene expression and (b) targeting these multi- subunit complexes with drug combinations and/or proteolysis targeting chimeras (PROTACs).